National Center for Quantitative Biology of Complex Systems

PROJECT SUMMARY – COMMUNITY ENGAGEMENT
Community Engagement is pivotal to the mission of the NCQBCS to advance biomedical research and
translational medicine through quantitative multi-omics technologies. That effort requires engaging with a broad
spectrum of potential users of these technologies. To that end, we will pursue three Specific Aims for CE that
build on our success 3.5 years into Cycle 1 in attracting new users and disseminating our new technologies. Our
strategy not only facilitates better technology development, but also ensures a long-lasting and sustained impact.
First, we disseminate our technologies through a six-fold strategy: (1) publications, (2) presentations, (3) patents
and technology transfer, (4) material transfer agreements, (5) open access software, and (6) web presence.
Second, we create and cultivate a broad user network through rigorous training programs, holistically targeting
entry level through advanced users. Third, we extend access to our technologies through Collaboration and
Service (C&S).